NADPH OXIDASE REGULATION OF THE MACROPHAGE INFLAMMATORY PHENOTYPE IN SEPSIS

ABSTRACT Acute lung injury (ALI) associated with Gram-negative sepsis is characterized by neutrophil- mediated inflammation that exhibits excessive morbidity and mortality. In spite of improved supportive care, there are currently no specific treatments for ALI that are based on the molecular pathogenesis of the syndrome. Our overall goal is to identify signaling mechanisms in pulmonary macrophages that regulate the activation of neutrophils that are crucial in mediating lung inflammatory injury. We have shown that inhibition of NADPH oxidase activity results in dampening of the transcription nuclear factor kappa B (NF-κB) activation in lungs that are treated with endotoxin without a reduction in cytokine generation or inflammation mediated by neutrophils. The mechanisms of increased inflammation seen in NADPH oxidase-deficient mice relative to wt have not been defined. Using reciprocal bone marrow chimera p47phox-/- wt mice, we observed that p47phox-/- bone marrow in wt mice resulted in enhanced NF-κB activation and neutrophilic inflammation in lungs LPS challenge. Our central hypothesis based on these data is that NADPH oxidase-generated ROS signaling converts macrophages from a pro- to anti- inflammatory phenotype during endotoxemia. We will address the postulate that this phenotype switch occurs via NADPH oxidase-generated ROS activation of a redox-sensitive Src, Lyn kinase, which in turn activate the SH2-containing phosphatidyl inositol phosphatase-1 (SHIP-1). In this model, Lyn kinase and SHIP-1 represent a critical signaling node that enhances PIP3 degradation to PI (3, 4) P2, which attenuates activation of Akt and thereby of NF-κB. This model will be interrogated in Aim 1 in which we will determine the role of NADPH oxidase-generated ROS signaling in the mechanism of the anti-inflammatory phenotype switch in macrophages. Further in Aim 2, we will identify the redox-activated signaling mechanisms downstream of NADPH oxidase generation of ROS in mediating the conversion in macrophage function and thereby identify the potentially important role of macrophages in mitigating lung inflammatory injury. By systematically delineating the role of NADPH oxidase in regulating the function of lung macrophages in modulating lung inflammation, we should identify novel signaling pathways that could provide novel therapeutic approaches to limit the injury.

Public health relevance
Our supporting data suggests that reactive oxygen species (ROS) have an important role in modulating an anti-inflammatory macrophage phenotype through negative regulation of the NF- κB activation pathway. We will dissect the involved mechanisms that link ROS to a role for macrophages in the resolution of lung inflammation which should lead to new treatments for acute lung inflammation.